Signaling activation and constraints in maintaining immune homeostasis

The innate immune system detects pathogen-derived molecules to prevent infections via specialized immune
receptors. The immune receptors include cell surface-resident pattern recognition receptors (PRRs), such as
Toll-like receptors (TLRs) in mammals and receptor kinases (RKs) in plants, and intracellular NOD-like
receptors (NLRs) in plants and mammals. Plant PRRs detect conserved pathogen-associated molecular
patterns (PAMPs), whereas NLRs recognize pathogen-specific effectors, culminating in a unified immune
system. How the signaling networks underlying PRR- and NLR-mediated immunity are interconnected remains
largely unknown. In addition, defects or over-activation of immune receptors could lead to cell death or
autoimmunity. Thus, understanding the mechanisms that enable or constrain PRR and NLR activation for
maintaining immune homeostasis is particularly important. The PI’s laboratory has developed a series of
sensitive and high-throughput genetic screens to dissect the complex activation and signaling mechanisms in
plant immunity, and revealed the importance of malectin-like RKs (MLRs) as a molecular module at the plasma
membrane linking PRR and NLR immune receptors. PI’s long-term goal is to elucidate the signaling networks
regulating innate immune responses using Arabidopsis as a model system and expand the knowledge of how
hosts fend off infections without causing autoimmune disorders. The proposed research rooted in PI’s previous
discoveries and preliminary studies will support a series of projects that address several critical knowledge
gaps in two interrelated research areas. First, the research will elucidate how the PRR- and NLR-mediated
signaling pathways converge into an interconnected and balanced immune response. Specifically, the projects
will mechanistically address how a PRR-activated MAP kinase cascade regulates NLR-mediated immune
homeostasis through MLRs perceiving different peptide ligands. Second, the research will decipher the
immune gene orchestration through the combinatorial action of the layered transcriptional, posttranscriptional,
and posttranslational regulations at the single-cell level. The projects will focus on how intertwined
posttranslational modifications, including ADP-ribosylation, ubiquitination, and phosphorylation, regulate
immune-specific gene transcription, stability, and translation. The proposed interdisciplinary research will
provide ample training opportunities for diverse undergraduate and graduate students and postdoctoral fellows.

Public health relevance
Project Narrative The molecular architecture of nonself recognition, including microbial perception and innate immune signaling, bears remarkable similarity from plants to worms, insects, and mammals. Our genetic and biochemical studies on elucidating the signaling networks orchestrating plant immune activation while avoiding autoimmunity reveal the molecular basis of plant defense and shed light on the evolutionarily convergent mechanisms in cellular signaling of animal innate immunity. Our study is relevant to the mission of NIH and is fundamental for basic medical research.